PSYCHONEUROLOGICAL ASSESSMENT IN DEMENTED PATIENT COHORTS H OMEGA-3 FATTY ACIDS

Various investigators in the Department of Neurology have developed several instruments to assess neuropsychological impairment in three demented populations: parkinson, alzheimer, and multiple sclerosis. CLINFO is used to data management and analysis in this project.